Electrophysiological Dynamics of Acute Opioid Use in Human Reward, Affect, and Pain Pathways

ABSTRACT
Opioid use disorder (OUD) and chronic pain (CP) are interrelated, both impacting the brain's reward, affect, and
pain circuits. OUD is prevalent among CP patients, and the euphoric effects and negative reinforcement
properties of opioids are significant factors contributing to an increased risk of abuse in this population. The
neural circuitry of OUD has been extensively studied using animal models and human neuroimaging, and an
overall reduced functional connectivity within the reward network has been found among CP patients and those
with OUD. However, the dynamic changes in connectivity from acute opioid use, and how these differ for CP
patients who are at risk of developing OUD remain largely unknown.
To address this gap in knowledge, we aim to uncover how acute opioid use impacts neural connectivity by
directly recording human neuronal signals from regions associated with OUD. These regions encompass
interconnected and overlapping circuits involved in reward, affect, and pain processing, and include: amygdala,
hippocampus, insula, orbitofrontal cortex (OFC), medial and ventrolateral and dorsolateral prefrontal cortex
(mPFC, VLPFC, DLPFC), anterior cingulate cortex (ACC), sensory thalamus, and periaqueductal gray matter
(PAG). To achieve this, we will leverage a unique ability to directly record local field potentials (LFP) from awake
humans, who have electrodes implanted for clinical purposes in deep brain regions, that opportunistically overlap
with areas implicated in OUD. These recordings will be obtained from two patient groups: 1) epilepsy patients
implanted with temporary brain electrodes for seizure monitoring (for 1-2 weeks), covering reward and affect
processing areas, and 2) deep brain stimulation (DBS) patients undergoing awake DBS placement surgery,
covering pain processing areas. Both groups routinely receive opioids to manage surgical pain, and both includes
a subset of patients who have chronic pain (CP). This enables us to compare neural activity during acute opioid
administration across individuals with varying degrees risk for developing OUD. In this project, patients will rate
their pain and mood levels on a scale (0-10) before and after receiving opioid pain medications, and the change
in reward/affect (Aim1) and pain (Aim2) network connectivity will be assessed, and further explored across
patients with varying degrees of risk in developing OUD (Aim3).
Through this K01 award, Dr. Ryu will lead the project and receive valuable mentored training by an
interdisciplinary team specializing in substance use disorder, neuromodulation, human brain signal processing,
and computational modeling. By the conclusion of the K01 award period, this research will reveal the
neurophysiological signatures within the addiction circuitry related to acute opioid use, offering valuable insights
for the development of future neuromodulatory treatments for OUD, and will further guide Dr. Ryu toward
achieving independence in this research field.

Public health relevance
PROJECT NARRATIVE Opioid use disorder (OUD) is prevalent among chronic pain patients, with the euphoric effects and negative reinforcement properties of opioids significantly contributing to an increased risk of abuse. This project aims to understand the impact of acute opioid use on the functional connectivity within the reward/affect circuits (Aim 1) and pain circuits (Aim 2) in chronic pain patients. It also seeks to explore how these dynamics differ among individuals with varying degrees of risk for developing OUD (Aim 3). Leveraging our unique dataset of invasive human neural recordings and the expertise of an interdisciplinary team, this project will provide valuable insights into the development of neuromodulatory treatments for OUD.